Researching Interventions and Implementation Strategies to Evaluate the Health and Development of Children Affected by HIV in Southern and Eastern Africa (RISE)

ABSTRACT
The Data Management and Analysis (DMAC) Core will oversee the design, development, implementation, and
dissemination of data-related infrastructure and analysis for all Projects in collaboration with the Cores. The
DMAC-specific objectives are: 1) To oversee data infrastructure for Projects 1 and 2 and data quality assurance
and data reporting for all four Projects, 2) To build data management and analysis capacity through cross-country,
interdisciplinary training opportunities across all Projects and sites (Botswana, Kenya, South Africa, Zimbabwe),
3) To develop statistical analysis plans and conduct statistical analyses for all Projects, 4) To ensure
harmonization of data systems and procedures across all Projects and Cores that support effective internal and
external dissemination of Program findings. We have assembled a team of experts in HIV/AIDS, maternal child
health, pediatrics, neurodevelopmental assessment, neuropsychology, clinical psychology, neuroimaging,
epidemiology, and biostatistics with experience implementing rigorous clinical trials and dyadic observational
studies in Africa. Our team is dedicated to high-impact science, as well as capacity building for research as a
result of the proposed Program. We will emphasize country-to-country data training to enhance regional
collaborations and knowledge-sharing. Our aim is for the DMAC data capacity-building approach to serve as an
exemplar of impactful training on research data procedures and methods to support HIV/AIDS and
neurodevelopment research globally. DMAC experts are well-suited to provide data services toward the overall
Program goal of providing insights into mechanisms, intervention, implementation/modelling and population
impact of in utero HIV/ART exposure in 4 countries in East and Southern Africa.